Task A71: Evaluation of Therapeutics and Vaccines in Mouse Models of Dengue Virus

This contract provides support for attendance and participation in the Collaborative Antiviral Testing Group Annual Meeting.